Molecular determinants of viral receptor-binding protein evolution; innovation, constraints, and evolvability

Project Summary
For over a decade our group has studied the coevolution of interactions between bacteriophage λ and
Escherichia coli as a model system to study species interactions as well as molecular interactions such as
between λ’s receptor-binding protein (RBP) and outer membrane receptors. Using this model system, we have
had success with studying many important subjects including the evolution of novelty, species, evolvability, and
complexity. The next stage of this research is to more thoroughly understand the molecular drivers of RBP
evolution, from understanding what types of mutations allow RBPs to gain new function, to what constrains
their evolution and the properties that enhance their evolvability. Recently, we published a molecular model for
how λ’s RBP evolves new function through a two-step process. The first is to gain mutations that destabilize
protein quaternary structure that cause the protein to form a range of confirmations, creating new geometries
of the RBP binding surface. Next, mutations in the RBP loops that create the binding surface evolve to further
augment the chemical properties of the surface to facilitate interactions with new receptors. This model is in
line with classic predictions that innovations evolve through non-genetic phenotypic heterogeneity (initial
destabilizing mutations that create confirmational heterogeneity) and then canalization of new function (loop
mutations). We propose to collect data on massive RBP genetic libraries to test this model and to further refine
it. To do this, we will use high throughput RBP gene-editing and phenotyping assays that we have developed
over the past decade. We will also assemble a library of 96 E. coli outer membrane proteins to test activity of
the RBP variants on a diversity of receptors. For Aim 1, we will test the molecular model by determining which
mutations cause RBP gain-of-function. Aim 2 builds on 1 by examining what protein characteristics constrain
RBP gain-of-function evolution and these data will be used to test protein tradeoff theories. Aim 3’s goal is the
opposite of Aim 2 and is designed to determine which protein features drive increased gain-of-function
evolvability. Aim 3 data will be used to test theories on protein robustness and evolvability. Overall, our goals
are to establish a molecular model for RBP gain of function that can be generalized to other viral systems with
the goal of predicting viral host-shifts, and to test general evolutionary theories on how novel protein-protein
interactions evolve, test which physical principals cause protein tradeoffs, and identify determinants of protein
evolvability.

Public health relevance
Project Narrative Receptor-binding proteins (RBP) of viruses have specialized interactions with host receptor molecules and mutations in them can cause viruses to shift hosts. Many studies have identified such gain-of-function mutations; however, a molecular model for how these mutations work that can be used to predict which viruses are likely to shift hosts has not been established. We will test and refine a molecular model for virus RBP gain-of-function evolution using new molecular and computational technologies including synthetic biology, high throughput sequencing, and artificial intelligence.